Targeting glutamate carboxypeptidase in perinatal brain injury

Project summary/abstract
Despite significant advances in neonatal care and implementation of therapeutic hypothermia, term and
preterm survivors of neonatal encephalopathy are at high risk for developing cognitive and learning deficits
even in the absence of functional motor deficits. Recent studies have implicated cerebellar dysfunction with the
long-term learning disorders seen in these children. Impaired Purkinje cell development has been linked to
impairment in cerebellar associative learning. Microglia have been shown to play a major role in the
development of Purkinje cells, the primary output neurons of the cerebellar cortex. Intrauterine inflammation
leads to microglial activation that results in maldevelopment of the Purkinje cells and cerebellar learning
deficits. Activated microglia in the cerebellum overexpress the enzyme glutamate carboxypeptidase II (GCPII),
which hydrolyzes the abundant neuropeptide N-acetylaspartylglutamate (NAAG, a specific agonist of the
metabotropic glutamate receptor, mGluR3) to N-acetyl-aspartate and glutamate. Reduced NAAG levels have
been linked to impaired cognition. This study proposes to specifically target microglial GCPII enzyme using
dendrimer conjugated to the nanomolar potent but poorly brain penetrating GCPII inhibitor 2PMPA (2-
(phosphonomethyl) pentane-1,5-dioic acid) (D-2PMPA). The central hypothesis is that normal microglial
function and dynamics play a critical role in cerebellar development, and inhibiting upregulated GCPII in
activated microglia with D-2PMPA will lead to increased NAAG in the cerebellum enabling normal Purkinje cell
development and improving cerebellar learning and memory in juvenile rabbits exposed to low dose endotoxin
in utero. This will be tested by (1) Evaluating the effects of low dose intrauterine endotoxin exposure on
Purkinje cell development, cerebellar microglial response and cerebellar learning (tested by classical eyeblink
conditioning reflex) in a rabbit model of maternal inflammation induced brain injury. (2) Evaluate efficacy of D-
2PMPA mediated microglial GCPII inhibition on Purkinje cell development and cerebellar learning at 6-8 weeks
of age in rabbits exposed to intrauterine inflammation and (3) Determine mechanisms of cerebellar
neuroprotection by D-2PMPA mediated by NAAG induced activation of mGluR3. This study will provide a
better understanding of how low-grade maternal-fetal inflammation in the perinatal period can lead to
cerebellar learning deficits long term. The proposed work is innovative because it uses a novel and potent D-
2PMPA conjugate to target microglial GCPII for addressing cognitive and learning deficits and enable normal
development of the cerebellum in a rabbit model of perinatal brain injury. This Multi-PI proposal will bring
synergistic expertise in perinatal/neonatal brain injury, neuropharmacology/GCP2 and nanomedicine, and
clinical translation to accomplish these aims. This work can lead to the development of novel therapies to
address learning deficits commonly seen with neonatal brain injury.

Public health relevance
Project narrative: The proposed research is relevant to public health because it provides a better understanding of the role of maternal infection and inflammation in the pathogenesis of neurodevelopmental disorders resulting in cognitive and learning deficits that would enable the development of specific targeted therapy for prevention of these disorders. Injury to the developing brain results in neurodevelopmental with large life time health care costs and very little treatment options. The works uses a translational research approach and is relevant to NIH’s mission to ensure application of knowledge to enhance health and reduce illness and disability.